Structure and Function of the Salmonella type III secretion sorting platform

PROJECT SUMMARY
Type III secretion systems (T3SSs) are widely distributed among important gram-negative
pathogenic bacteria. These complex specialized machines have evolved to transfer multiple
bacterial-effector proteins into host eukaryotic cells to modulate a variety of cellular functions and
they are essential for pathogenicity. The central component of T3SSs is a multi-protein structure
known as the “injectisome”. This structure is composed of the envelope embedded needle
complex (NC), and a cytoplasmic sorting platform (SP) that selects the substrates and energizes
the secretion process. This research project focuses on the structural and functional
characterization of the sorting platform. Through a multidisciplinary approach involving bacterial
genetics, biochemistry, super-resolution microscopy, cryo-EM and cryo-ET, we intend to
investigate the sorting platform structure and function, and in particular, the mechanism by which
client proteins are selected and sorted. These studies will provide insight into poorly understood
aspects of T3SS function. Importantly, given the high degree of conservation of this machine in
many important pathogenic bacteria, knowledge gained with these studies will contribute to the
understanding of T3SS in general, and therefore, generate knowledge that could be leveraged in
fighting bacterial pathogenesis.

Public health relevance
PUBLIC HEALTH RELEVANCE Many important bacterial pathogens such as Salmonella, Yersinia, Shigella, E. coli, Pseudomonas aeruginosa, Burkhodleria spp., Chlamydia spp., and Bordetella pertussis possess specialized nanomachines known as the type III protein secretion systems (T3SSs), which are essential for their ability to cause disease. These machines “inject” bacterial proteins into the cells of the host to alter cellular functions for the pathogen’s benefit. This project intends to study how an essential component of these machines exerts its function, which could provide the bases for the development of broadly active anti-infective strategies.